Research Experience and Training Coordination Core

PROJECT SUMMARY (Research Experience and Training Coordination Core: Maier, Ramírez-
Andreotta, Zhang)
The overarching goal of the University of Arizona Superfund Research Program (UA SRP) is to improve human
health and the environment by investigating the impacts of metal mining. Achieving this goal requires socially
responsible mining and the development of transdisciplinary, research-based, paradigm-shifting solutions to the
multifactorial problems associated with the increased demand for metals. Such solutions require the continual
development of new research capacity. The UA SRP Research Experience and Training Coordination Core
(RETCC) supports this effort by preparing interdisciplinary graduates who are equipped to address and mitigate
complex 21st century hazardous waste challenges. The success of the UA SRP Trainee experience is evidenced
by the number of awards they receive and by their successful placement upon graduation into sought after
academic, regulatory, and industry positions. We involve undergraduate and graduate students as well as post-
docs in our training mission. As well, our Trainees are intimately involved in the scientific discoveries made by
the UA SRP and in presenting these discoveries to the science community and the general public. The goal of
our RETCC is to provide comprehensive training opportunities in science, research translation, community-
engaged research, and data management supported by interdisciplinary collaborations among our research
projects and cores. To this end, the RETCC will provide career enhancement stipends to up to ten Trainees each
year to participate in: (1) a cohort development retreat; (2) a new innovative year-long course that combines
monthly Colloquium with professional development, data analysis and management, and science
communication activities; and (3) a Community Engagement Core or Research Translation activity. Any student
or post-doc affiliated with or supported by a UA SRP project/core is eligible to be an official Trainee and
participate in our formalized RETCC activities. To achieve our goal, we have devised the following RETCC
objectives: (1) Provide Trainees access to intensive and extensive training opportunities in biomedical and
environmental sciences as well as data management and analysis; (2) Require Trainees to become familiar with
the language and culture of multiple scientific disciplines through our Colloquium and professional development,
data analysis, and science communication curriculum as well as attendance at professional meetings
encompassing different disciplines; (3) Require Trainees to participate in one research translation or community
engagement activity related to our Center goals; (4) Require Trainees to understand best practices in the
responsible conduct of research; (5) Incorporate community-engaged research concepts and experience into
each Trainee’s education; and (6) Provide multi-mentor apprenticeship opportunities to our Trainees. By
addressing our objectives, the RETCC will produce passionate, mission-driven, environmentally aware scientists
trained to address the social and ethical aspects of resource extraction and to consider the impacts of mining on
community health and well-being as well as the production, use, and reuse of metals.